2024 Mammalian Reproduction Gordon Research Conference and Gordon Research Seminar

Project Summary
The major goal of the 2024 Gordon Research Conference (GRC) on Mammalian Reproduction is to bring
together a diverse and accomplished group of scientists from all over the world to exchange their most recent
and cutting-edge research in mammalian reproductive sciences. The conference will begin with a Gordon
Research Seminar (GRS) specifically led by two young reproductive scientists and focused to enhance the
professional development of postdoctoral and graduate student trainees who will participate in this exciting
conference. Thus, through complementary and synergistic scientific and professional development programs,
the 2024 GRS and GRC on Mammalian Reproduction will promote the following objectives throughout this
conference: we will establish a highly positive and non-threatening atmosphere where researchers at all stages
of career development and from diverse backgrounds can share their cutting-edge research, gain valuable
feedback and expand their professional and academic networks; we have and will continue developing a
scientific program that attracts the leading and inclusive researchers in basic, agricultural, and clinical
reproductive sciences from around the world, including women and under-represented minorities, at all stages
of career development; we will support the growth and development of early career scientists from diverse
backgrounds in reproductive biology research to fully participate in this conference; and we will expose all
participants at this conference to the most cutting-edge and game-changing research developments in
reproductive sciences and promote critical and professional discourse from all and especially those with
previously less representation to engage openly and honestly about these discoveries and their potential global
impact. By completing these major objectives, we will contribute to the current and future development of the
field of reproductive scientists where scientist from all backgrounds will be welcomed and succeed in this
important scientific area.

Public health relevance
Project Narrative The 2024 Gordon Research Conference on Mammalian Reproduction aims to promote the understanding of fundamental processes guiding reproductive functions in mammals, foster new research collaborations and enhance the career development of trainees and junior investigators. We will promote the participation of trainees, women, and individuals from underrepresented groups in all aspects of the program. The overarching goal is to assemble a diverse and international community of experts in reproduction to share cutting-edge discoveries that advance the frontier of research that impacts reproductive medicine and human health.